UroEDIC Bladder: Bladder Dysfunction in Type 1 Diabetes

PROJECT SUMMARY
The Diabetes Control and Complication Trial (DCCT) and its observational follow up Epidemiology of Diabetes
Intervention and Complications (EDIC) represent landmark achievements in diabetes research. The DCCT
enrolled 1441 men and women with type 1 diabetes (T1D) in a randomized trial of intensive vs. conventional
insulin therapy, delaying the onset and progression of diabetic complications and dramatically changing the
management of patients worldwide. Implementation of tight glycemic control has reduced the frequency of
devastating complications of T1D such as early death, blindness and amputation. Women and men with T1D
face new challenges including cognitive decline, autonomic dysfunction and urological disorders. UroEDIC, an
ancillary study examining urological complications in the DCCT/EDIC cohort, combines over 25 years
of detailed medical information and >90% participation in urological symptom assessment annually
since 2010, making it the longest running most extensive urological evaluation of persons with T1D.
The previous funding cycle identified lower urinary tract symptoms (LUTS) and urinary incontinence (UI) as
urological disorders in men and women with T1D with the highest prevalence and greatest impact on quality of
life (QOL). By linking powerful longitudinal urological phenotypes with extensive clinical and laboratory data of
the DCCT/EDIC, we can substantially deepen our understanding of diabetes associated urinary complications.
Preliminary analyses show that although many patients develop a fixed state of LUTS or UI, many others move
in and out of the state over time. Our overall hypothesis is that metabolic, autonomic and epithelial
dysfunctions are associated with persistent and reversible subphenotypes of LUTS and UI in men and women
with diabetes. Observations also indicate bladder overactivity in both genders is increasing in this cohort.
However, there is a lack of understanding of the burden and impact of other diabetic bladder problems,
particularly diabetic cystopathy, classically described as decreased bladder sensation, poor contractility and
high residual urine volume. The goals of UroEDIC Bladder, therefore, are to 1) characterize the full spectrum
of bladder dysfunction in T1D, 2) create risk models that explain the progression and remission of LUTS/UI,
and 3) identify mechanistic themes underpinning the persistence of these symptoms. The specific aims of
this project are designed to incorporate newly proposed and available longitudinal data on bladder
retention, autonomic dysfunction and novel transcriptional signatures with the full range of
DCCT/EDIC measurements to gain deeper insight into the longitudinal patterns and mechanisms of
LUTS/UI and comprehensively characterize diabetic bladder dysfunction in T1D.

Public health relevance
PROJECT NARRATIVE To advance our understanding of bladder dysfunction in type 1 diabetes (T1D), this project links existing information on diabetes severity from a large NIH study to new assessments of urinary symptoms and bladder dysfunction and urine specimens for gene expression analyses. This work will contribute comprehensive critical data to expand our knowledge about the natural history and molecular mechanisms of bladder dysfunction in T1D.